Administrative Core

The Administrative Core provides the overall leadership for this U19 study,
Resistance/Resilience to Alzheimer's Disease in Centenarians and their Offspring
(RADCO) and it acts as the communication hub for the 3 cores and 2 projects, NIA scientific
officers, the Lead PI for the Single IRB and the OSMB (the RADCO community). The core
supports and encourages optimal interactions amongst the RADCO community in part by
facilitating all of the study-wide, core- and project-specific video conference calls and posting the
minutes and action items on the Study's internal Confluence-based website. The Core provides
the leadership of the Publications and Presentations and Ancillary Studies Committees and
orchestrates triannual RADCO-wide video conference meetings to discuss progress in achieving
the aims, to update everyone on what others are doing and provides, particularly for junior
investigators, opportunities to present their work. In years 2 and 4, the Spring meeting is held in
person in Bethesda. The Administrative Core also coordinates with NIA staff, biannual meetings
with the OSMB. The Core leads the outreach to the greater scientific community with the creation
and maintenance of the RADCO's public facing website and orchestration of publicly available
and well-advertised biannual scientific workshops. These scientific outreach efforts also include
implementation of NIA's Alzheimer's Disease-related data sharing policy by working with the
Phenotyping and Biospecimen and the Neuroimaging Cores to perform quality control, curation
and transfer of all generated data to the AD Knowledge Portal within 3 months of the data
becoming available for analyses. All of these responsibilities are integral to successfully achieving
the goals of the proposed research and they are reiterated as the following specific aims.